An Application of SMART Methodology to Optimize an Intervention to Maintain Improvements in Health Behaviors in Under-resourced Patients after Phase II Cardiac Rehabilitation

PROJECT SUMMARY/ABSTRACT
Cardiovascular disease (CVD) is the leading cause of death in the United States. Cardiac rehabilitation (CR) is
an evidence-based, cost-effective, and widely available multidisciplinary program that combines supervised
exercise with psychoeducation on health behavior change aimed at improving overall health and reducing
cardiovascular risk in individuals with established CVD. However, under-resourced and underserved CVD
patients (e.g., women, racial and ethnic minorities, low socioeconomic status, disabled) are less likely to
maintain their adherence to key cardioprotective behaviors (weight management, physical activity [PA], and
medication adherence) after CR and are under-represented in post-CR research; these factors combined
increase the health disparities in CVD care that these sub-populations experience, especially since many
cannot complete self-pay Phase III maintenance programs. In the PI’s previous work, under-resourced and
under-represented patients indicated that they want technology-based maintenance support interventions that
utilize technology they already own, are minimal burden, offer a flexible schedule, offer more support for
patient needs without overwhelming them with program requirements before demonstrating that a lower level
of support was insufficient, and produce desired results. Patients felt resistant to initiating a demanding, time-
intensive, or in-person maintenance intervention immediately following CR. The present application utilizes a
Sequential, Multiple Assignment, Randomized Trial (SMART) design to create a stepped care model that
adapts to patient needs and minimizes patient burden. Participants (N=400) will be randomized to receive
either a low-intensity text messaging intervention or an automated online program for 2 months and determine
which produces superior adherence (Aim 1). Following classification as intervention responders or non-
responders, responders will continue receiving their initial low-intensity intervention. We will then determine
whether low- or high-intensity home-based CR (with or without case management) for 3 months produces
better behavioral adherence following failure of a low-intensity intervention failure (Aim 2). We will then finalize
the ideal adaptive intervention based on Aims 1 and 2 results and moderator analyses (Aim 3). Patients will
complete post-intervention assessments at 6 months and exploratory outcomes assessment (death,
rehospitalization, quality of life). This research will result in a stepped care model for under-resourced patients’
behavioral adherence maintenance following CR. This project advances the science of CVD treatment and
post-CR care, and it will directly impact CVD patient outcomes by extending the benefits of evidence-based,
effective care as well as target health disparities among less-resourced CVD patients.

Public health relevance
PROJECT NARRATIVE Cardiac rehabilitation (CR) is an evidence-based, available, reimbursable treatment for cardiovascular disease (CVD) that reduces secondary cardiovascular risk, but adherence to cardioprotective behaviors established during CR (weight management, physical activity [PA], medication adherence) diminish with time effectively furthering health disparities in cardiovascular care; this represents a public health crisis. This study will use the Sequential Multiple Assignment Randomized Trial (SMART) design to develop an adaptive stepped-care intervention sequence for 400 under-resourced or under-represented CR patients following CR graduation intended to rescue patients from non-adherence and preserve cardioprotective behavior engagement. The technology-based interventions will be evaluated across 6 months, and the primary outcome is to determine the best intervention for adherent and non-adherent patients measured by adherence to the 3 key behaviors.